Portable TMS-EEG device for bedside detection of covert consciousness

Project Summary
Disorders of consciousness (DoC) due to severe brain injury affect more than one million people
worldwide each year. Withdrawal of life-sustaining therapy (WLST) is the cause of ~80% of deaths in
patients with DoC in intensive care unit (ICU) settings; yet WLST decisions are often made by families
and caregivers without a clear understanding of their loved one’s state of consciousness or potential for
recovery. Over the last twenty years, the physician-scientists who founded Intrinsic Powers, Inc. and the
PI developed and validated a method combining transcranial magnetic stimulation (TMS) with
electroencephalography (EEG) that has unprecedented sensitivity and specificity (>95%) to diagnose
covert consciousness. However, this method requires lengthy data acquisition and processing with 60
EEG channels, which makes it impractical in ICU settings. In the present STTR, Intrinsic Powers and the
PI and her team propose to fill this gap by developing Presence, a new portable TMS-EEG device
combining a new complexity algorithm, Presence-IP1.0, computed in real-time with 21 electrodes and
without the need for an MRI, combined with a portable data acquisition system integrated into a wheelable
cart, that will maximize the clinical utility for the ICU. In this Phase 1 STTR, we propose to: 1) refine the
product vision and value propositions for the use of Presence in the ICU; and 2) validate the accuracy of
the new Presence-IP1.0 algorithm on a prospective dataset. Our product vision and value proposition
(Aim 1) will be refined through systematic semi-structured interviews of end-users and stakeholders to
define how Presence will help to guide clinical decision-making and to ascertain the optimal trade-off
between accuracy and user-friendliness to maximize clinical utility (Aim 1). Our milestone for Aim 1 will
be the collection of 100 semi-structured interviews. In parallel, we will validate the accuracy of Presence-
IP1.0 to detect consciousness in a prospective sample of 30 subjects (half from ethnic minorities)
acquired with TMS combined with 21 EEG channels during wakefulness and sleep (Aim 2). Our milestone
for Aim 2 will be to show that Presence-IP1.0 can achieve clinically useful accuracy (as determined by
user feedback from Aim 1) to differentiate conscious from unconscious states in the prospective dataset.
Finally, for Aim 3, we will hold a PreSubmission meeting with the FDA. The work performed in this Phase
I STTR will open the way to Phase II multi-centric ICU studies to validate the diagnostic and prognostic
utility of Presence in the ICU. We expect Presence to become widely used, triggering a transformative
shift in the care of DoC patients in the ICU by enabling physicians to detect consciousness and predict
patients’ recovery even in difficult cases quickly and precisely. Such innovative technology will
significantly decrease burn-out of families and caregivers and reduce costs of care thanks to a decreased
length of ICU stays and a more efficient distribution of limited life-saving ICU resources.

Public health relevance
Project Narrative This project will transition a highly sensitive and specific method for detecting consciousness in behavioral unresponsive patients, based on computing brain complexity following transcranial magnetic stimulation (TMS) of the brain and recording from electroencephalography (EEG) electrodes, from a research prototype into a clinical device, called Presence, combines a TMS-EEG system on a wheelable data acquisition cart with a new algorithm (Presence-IP1.0), with many fewer EEG electrodes (21 rather than 60), faster acquisition time and without the need of a patient-specific MRI. In this Phase 1 STTR, Intrinsic Powers, Inc. and the PI propose to further refine product vision and value propositions for Presence, and to validate the accuracy of the new algorithm to detect consciousness in a prospective dataset of healthy subjects during wakefulness and sleep - laying the foundations for a multi-centric Phase 2 clinical study in multiple centers, further validating the diagnostic and prognostic utility of Presence in ICU settings. The outcome of this STTR will be a diagnostic and prognostic tool, a consciousness detector, to greatly improve the standard of care and inform decisions about life-sustaining therapy for patients with disorders of consciousness.